Targeting the Renin System for the Treatment of Pain and Opioid Use Disorder

Project Summary ______
Chronic pain is a pervasive condition that impacts an estimated 20% of the population with close to 8% of
individuals experiencing high-impact pain that severely restricts daily activities. Opioid analgesics are the most
powerful and effective medications for reducing acute pain and are a frontline resource for analgesia in chronic
pain patients. However, repeated use of opioids is associated with analgesic tolerance, greater sensitivity to
nociceptive and non-nociceptive stimuli (i.e., opioid-induced hyperalgesia/allodynia), and a risk of developing
opioid use disorder (OUD). OUD is characterized by an escalation of opioid use over time and a parallel
development of intense negative emotional states. Central to this conceptualization is the continued use of
opioids to self-medicate both somatic and emotional pain in individuals suffering from OUD. These factors
have contributed to the current prescription opioid epidemic, which is a national health crisis hallmarked by
skyrocketing reports of opioid misuse and overdose deaths. The elucidation of novel pathophysiological
mechanisms driving the escalation of opioid use and opioid-associated pain are desperately needed, spurring
the NIH Helping to End Addiction Long-Term (HEAL) initiative to support the early-stage discovery of new pain
and OUD targets. For this proposal, we have identified renin inhibition as a highly promising strategy in accord
with this initiative, particularly since the FDA-approved renin inhibitor, aliskiren, is clinically available for treating
hypertension and well tolerated in most individuals. More recent studies have described a beneficial role for
aliskiren to reduce hyperalgesia symptoms in a diabetic neuropathy pain model, although its effects on opioid-
related pain are unknown. In preclinical animal models of OUD, we have shown that escalated and extended
access to fentanyl produces a profound mechanical allodynia and increased pain avoidance-like behavior in
rodents. Our more recent work has shown that extended access (long access, LgA) to self-administered
fentanyl produces escalated fentanyl intake and increased motivation for fentanyl in male and female rats
compared animals given limited access (short access, ShA) to fentanyl. With this comprehensive model, we
are prepared to directly test our overall hypothesis that renin inhibition will reduce the escalation of fentanyl
self-administration and significantly alleviate hyperalgesia/allodynia and pain avoidance-like behaviors in
fentanyl self-administering animals. This proposal examines an FDA-approved therapeutic strategy (direct
renin inhibition) to target an understudied molecule (renin receptor) as a novel therapeutic avenue for the
treatment of OUD and pain. These studies will be conducted in a research environment that features
substantial expertise in behavioral neuroscience and neuropharmacology within a comprehensive physiology
department and drug abuse center that will maximize the translational potential of these and future directions.

Public health relevance
Project Narrative ______ Repeated use of opioids to treat chronic pain is associated increased pain sensitivity and a risk of developing opioid use disorder (OUD). There is a clear need to support the early-stage discovery of novel analgesic and OUD medications within druggable physiological systems. Our proposal aims to examine an FDA-approved therapeutic strategy (direct renin inhibition) as a novel therapeutic avenue for the treatment of OUD and pain.